Prions in the bacterial domain of life

ABSTRACT
Prions are infectious, self-propagating protein aggregates that were first described in the context of the
transmissible spongiform encephalopathies (TSEs), fatal neurodegenerative diseases afflicting humans and
other mammals. The culprit is an endogenous protein called PrP that has an inherent ability to misfold,
resulting in the formation of distinctive cross-β aggregates (termed amyloid) that are both self-templating and
infectious. Prions have also been uncovered in budding yeast, where they act as protein-based genetic
elements that confer new heritable phenotypes on those cells that harbor them. Like PrP, fungal prion proteins
can access alternative conformational states, a soluble form and a self-perpetuating, amyloid form (the prion
form) that is infectious. However, fungal prions do not typically cause cell death. Our demonstration that
bacterial cells could support the propagation of a model yeast prion led us to search for bacterially encoded
prion proteins. The initial identification of two bacterial prion proteins and the development of E. coli-based
models for investigating their behaviors provide a foundation for the proposed studies. An overarching
hypothesis informing our work is that protein-based heredity serves as an epigenetic source of phenotypic
diversity in bacteria. Our research goals are to investigate the physiologic impacts of bacterial prions, the
cellular determinants of prion formation and propagation, the sequence and structural determinants of heritable
amyloid, and the scope of prion-like phenomena in bacteria. Having uncovered functional prion domains in 17
bacterial single-stranded DNA-binding proteins (SSBs), we are focusing our physiological studies on SSBs,
while also using them as models to address mechanistic questions about prion formation and propagation. On
the one hand, we are genetically dissecting the prion proteins themselves and subjecting informative mutants
to high-resolution structural analysis. On the other hand, we are poised to identify cellular factors that alter the
behavior of these proteins, either hindering or facilitating prion formation and propagation. To date, our studies
have centered on computationally identified bacterial prion proteins. However, existing algorithms would not
have identified PrP and several noncanonical fungal prion proteins, motivating us to use novel genetic
strategies to identify candidate prion domains irrespective of their sequence characteristics. Fundamental
questions that permeate multiple aspects of our work are (i) what distinguishes heritable amyloid from non-
heritable amyloid and (ii) what enables certain prion-like assemblies to nucleate the formation of other prions,
questions relevant to the understanding of disease-related prion-like phenomena, including a growing body of
evidence that bacterial amyloid can facilitate the aggregation of human proteins involved in neurodegeneration.
A separate set of investigations centers on translational fidelity and non-programmed ribosomal frameshifting
(NPRF). Building on recent findings, we are investigating the mechanistic basis for an unexpected promiscuity
among NPRF events in bacteria, as well as striking organism-specific differences in translational fidelity.

Public health relevance
Project Narrative First uncovered in the context of the fatal transmissible spongiform encephalopathies, prions are infectious, self-propagating protein aggregates that also exist in yeast and other fungi, where they act as heritable, protein-based genetic elements that can enhance survival under specific stressful conditions. The more recent discovery of bacterial prions provides the foundation for the proposed studies, which will use bacterial models to investigate the intrinsic and extrinsic determinants of prion formation and propagation, while also exploring the scope and impact of prion-like phenomena in bacteria. The human health implications of bacterial prions could be far-reaching, from potential roles in antibiotic tolerance and immune evasion in the context of infection to potential effects on the human proteome via cross-Kingdom templating interactions within the human microbiota.